Vaccine Immunity to Attenuated Coccidioides

? DESCRIPTION (provided by applicant): Coccidioidomycosis is a serious respiratory disease in the Sonoran Desert of southern Arizona and the central valley of California. There is currently no effective vaccine; some people can require life-long treatment with expensive antifungals. The goal of this R21 application is to understand the mechanism of protective immunity elicited by a novel attenuated mutant of Coccidioides, Δcps1. Preliminary data demonstrates both safety (no disease in profoundly immunocompromised mice) and profound protection from subsequent infection with wild-type Coccidioides in otherwise susceptible mice. Information is incomplete concerning the immune response(s) induced vaccination and which are responsible for protection are unknown. Here we will use the approaches of modern cellular immunology to determine the cellular mechanism of vaccination and which of the induced responses to Δcps1 are responsible for protection.

Public health relevance
PUBLIC HEALTH RELEVANCE: Valley Fever is a respiratory disease endemic to the Southwestern United States. It sometimes causes a serious life-long infection. This proposal addresses the mechanisms of protection of a candidate live, attenuated vaccine, and prepares the way for further testing in large animals and humans.